Biophysics Core Facility

The services that the Biophysics Core Facility provides to the NIH scientific community consist of four main categories: direct research support including instrument use, collaborations on research projects and scientific consultations, development and optimization of measurement methods, and user training. Yearly laboratory workload of the Biophysics Core Facility exceeded 3,000 instrument hours. Biophysics Core Facility users include principal investigators, staff scientists, postdocs and students from over 60 NIH laboratories. NIH laboratories served by the NHLBI Biophysics Core (listed by the PIs last name): Altan-Bonnet, Nihal; Ferre-DAmare, Adrian; Jiang, Jiansen; Kemper, Claudia; Korn, Edward; Lee, Jennifer; Levine, Rodney; Neuman, Keir; Peterkofsky, Alan; Porter, Lauren; Remaley, Alan; Rusan, Nasser; Sellers, James; Swenson, Rolf; Tjandra, Nico; Adhya, Sankar; Caplen, Natasha; Chattoraj, Dhruba K.; Escorcia, Freddy; Fitzgerald, David; Ho, Mitchell; Jones, Jennifer; Larson, Daniel; Lee, Kyung; Mock, Beverly; Ramamurthi, Kumaran; Roberts, David; Steeg, Patricia S.; Tanner, Kandice; Zhurkin, Victor; Buchanan, Susan; Bernstein, Harris; Dyda, Frederick; Hinton, Deborah; Kovac, Paul; Liang, Jake; Masison, Dan; Mizuuchi, Kiyoshi; Philpott, Caroline; Prinz, William; Rehermann, Barbara; Star, Robert; Usdin, Karen; Xu, Peng; Yuen, Peter; Zhang, Jinwei; Loh, Yoke Peng; Storz, Gisela; Machner, Matthias; Zimmerberg, Joshua; Chiorini, Jay; Tabak, Lawrence; Farber, Joshua; Jin, Tian; Marcotrigiano, Joseph; Otto, Michael; Cookson, Mark; Ramsden, Chris; Fischbeck, Kenneth; Holmgren, Miguel; Koretsky, Alan; Friedman, Tom; Redmond, Thomas Michael; Wistow, Graeme; Schuck, Peter; Simeonov, Anton; Gibbons, Gary; Liu, Paul.